Administrative Supplement to Building equity in cancer screening through research: The Siteman Catchment CSRN Hub

This application is being submitted in response to the NOSI identified as NOT-CA-24-111. The CSRN
ACCESS Hub at Siteman Cancer Center and Washington University in Saint Louis is committed to bringing
cutting-edge cancer screening research to our Midwest region, including rural and urban areas in Missouri and
Illinois. Improving early detection is critical to reducing the burden of cancer in the US, and has the potential to
reduce disparities in cancer outcomes. Emerging technologies for screening may have particular benefit for
medically underserved and health professional shortage areas that have less access to healthcare and more
need for early detection. However, to achieve this goal, research must not only include community members
with these backgrounds, we must consider those communities in research design and conduct. Research
conducted at the Siteman Catchment ACCESS Hub will prioritize scientific rigor and ensure enrollment in
communities previously under-represented in cancer screening research including rural, low-income, under-
and un-insured, and representation from diverse races and ethnicities. Our CSRN Hub is led by an
experienced multi-disciplinary team with expertise in cancer screening research and in developing partnerships
with community health systems.
With this Administrative Supplement, we propose to participate in the CSRN Vanguard Trial for Multi-Cancer
Detection. We bring a collaboration between Siteman Cancer Center and six community-based healthcare
systems in Missouri and Illinois. We propose to enroll 2000 people over 2 years of recruitment into the
Vanguard trial, with at least 50% of participants from rural areas, and 25% from racial and ethnic backgrounds
under-represented in research. Our efficient and time-tested approach to partnership across institutions will
maximize success in recruiting participants across our broad region and meeting enrollment goals. We will
collaborate with community health systems in launching the trial, and work with them to recruit, consent, and
enroll participants from across our region, while also recruiting across our St Louis region. We will develop
tracking procedures to engage in continuous monitoring and improvement of recruitment, and apply processes
to monitor study implementation, successes, challenges, and solutions throughout the study. We will have
processes and supports to ensure baseline data are collected in full, maintain contact with participants
between baseline and follow-up, work with participants to collect follow-up data, and support participants in
achieving diagnostic follow-up if their MCD screening test should be positive for cancer. We have deep
relationships within our community, partnership with trusted local systems, careful attention to messaging,
research expertise, and will deploy multiple strategies to reach participants and allow them to participate – all
to ensure success of the Vanguard trial and its aims. We are already collaborating on Vanguard workgroups
across the CSRN, and will work with NCI and the CSRN to follow the Vanguard protocol and operations.

Public health relevance
PROJECT NARRATIVE Improving screening and early detection is crucial for reducing the growing burden of cancer in our society. Such efforts have the potential to reduce cancer disparities and inequities if research is designed and conducted with equity and accessibility in mind. For the Cancer Screening Research Network, the Siteman Cancer Center Catchment Hub is focused on building equity in cancer screening through research and engaging diverse community members across Missouri and Illinois in this effort. Our multi-disciplinary team and region-wide partners are committed to ensuring the success of the Vanguard trial and its aims.